Mentoring the next generation of patient-oriented translational virologists

PROJECT SUMMARY
There is an urgent need for translational virologists and physician scientists, who are trained in translational
patient-oriented research, have expertise across clinical/laboratory science, and can bridge the gaping divide
that often occurs between purely clinical and laboratory-focused researchers. Translational HIV virologists are
instrumental to the success of clinical trials networks, collaboratories, and for our goal to translate basic
laboratory findings into novel therapeutics. However, it has become increasingly clear to me that the pipeline
for translational HIV researchers has slowed to a trickle. The primary goal of this project will be to provide
mentorship to trainees and early career investigators in clinical studies and cutting-edge translational virology
techniques in key priority areas of HIV. Among the top priorities of the HIV field is the determination of the
mechanisms behind HIV persistence, the search for therapeutic interventions that can lead to sustained
antiretroviral therapy (ART)-free HIV post-treatment control, and the impact of HIV drug resistance to newer
antiretroviral agents (ARVs). Trainees will have the opportunity to both lead and study participants from high-
priority cohorts, such as the Low-V cohort of participants with non-suppressible viremia, the Control of HIV
after Antiretroviral Medication Pause (CHAMP) study, the largest study of post-treatment controllers world-
wide, and new HIV cure and treatment trials from the ACTG. This will be paired with training in cutting-edge
laboratory techniques like the Matched Integration Site and Proviral Sequencing (MIP-Seq) and single-cell
techniques for an in-depth analysis of the molecular circuits of HIV persistence and reservoir control. This is
also an exciting time for HIV therapeutics with the rollout of dolutegravir in Africa and the introduction of long-
acting injectables in the US. However, progress could be reversed with increasing drug resistance. We have
developed robust next-generation sequencing platforms for HIV resistance sequencing and will use cohorts
from the ACTG and sub-Saharan Africa to evaluate the prevalence and clinical impact of antiviral drug
resistance mutations. Trainees will also have access to individualized training in virology, clinical trial design
and implementation, biostatistics, and bioinformatics courses and co-mentors. With the successful completion
of this project, we will have 1) trained the next generation of investigators to provide leadership and virology
support for clinical studies focused on HIV; 2) advanced our understanding of the mechanisms of HIV
persistence and control in PTCs, with implications for the design of HIV curative strategies for all individuals
living with HIV, and 3) defined the impact of antiviral drug resistance and viral evolution to our newest ARVs.

Public health relevance
PROJECT NARRATIVE The primary goal of this project will be to provide mentorship to trainees and early career investigators in clinical studies and cutting-edge translational virology techniques in key priority areas of HIV research. Trainees will help lead research to 1) Determine the virologic features of HIV persistence, 2) reservoir mediators of post-treatment HIV control, and 3) Assess the impact of emerging HIV resistance to new antiretroviral agents. The results of the studies will also advance our understanding of the mechanisms of HIV persistence, post-treatment control, and the clinical impact of antiviral drug resistance.